Skeletal muscle sarcomere function in health and disease

Abstract
Skeletal muscle accounts for 40% of body mass and defines in significant ways who we are as human beings.
From the essential underpinnings of breathing, to the basic day-to-day movements of sitting, standing, and
walking, skeletal muscle function enables the fullness of the human condition. Numerous skeletal muscle
diseases cause marked contractile dysfunction leading to significantly diminished overall wellbeing and lifespan
in humans. Therefore, preventing or reversing muscle dysfunction has significant health relevance. This proposal
focuses on the sarcomere - the functional unit of striated muscle – known to underlie multiple forms of contractile
dysfunction. In Nemaline myopathy, severe muscle weakness arises from hypoactive sarcomeres, while the
severe muscle contractures characteristic of Distal Arthrogryposis stem from hyperactive sarcomeres. Other
disorders, including inherited Muscular dystrophies, also involve altered sarcomere function. These diseases
establish the sarcomere as a crucial, yet highly underserved, target for therapeutic intervention. Skeletal muscle
diseases involving defective sarcomeres have no cure or effective treatments. A major challenge to progress
centers on the inherent complexities of sarcomere regulation. Recently, novel ON/OFF myosin cross-bridge
activation states under mechano-sensing regulatory control have been proposed to interface with the troponin-
tropomyosin system to regulate contraction. Working together, through dynamic inter-myofilament signaling, this
new view of sarcomere regulation has significant implications for muscle health and disease. To date, the data
supporting this model derives mainly from biophysical studies, with physiological relevance unclear and critical
to elucidate. We developed and validated a novel FRET-based sarcomere activation biosensor integrated into
the myofilaments of intact skeletal muscle. Preliminary data shows the biosensor detects conformational
changes in troponin, serving as a signaling nexus for real time reporting load-dependent inter-myofilament
signaling regulation of sarcomere activation during physiological contractions in live skeletal muscles. Guiding
hypothesis: Healthy skeletal muscle function requires precise sarcomere activation accomplished by dynamic
inter-myofilament signaling wherein thin filament regulation initiates and myosin sustains sarcomere activation
during physiological contraction; consequently, defective inter-myofilament signaling causes disease. The Aims
are to investigate physiological mechanisms of inter-myofilament signaling in regulating sarcomere activation
during twitch contractions in intact skeletal muscles and to investigate the effects myosin binding protein C as a
key mechano-sensor governing inter-myofilament signaling processes in regulating sarcomere activation during
twitch contractions in intact skeletal muscles. Elucidating the mechanisms underlying physiologically relevant
mechano-sensitive inter-myofilament signaling will provide the essential framework for advancing new
therapeutic discoveries to retain healthy skeletal muscle performance throughout lifespan, and to restore normal
skeletal muscle function in inherited myopathies.

Public health relevance
Public health relevance This proposal incorporates leading-edge genetic and physiological studies to investigate contractile proteins that control skeletal muscle performance in health and in disease. Therefore, the health relevance of the proposal is substantial and highly significant to the mission of the National Institutes of Health.